Role of carboxyl-terminal modulator protein in autophagy and senescence of human induced pluripotent stem cells

Alzheimer’s disease (AD) is the most common form of dementia in the elderly. Aging is the
most significant risk factor for AD. It is known that brain aging is with decreased autophagy, a
biological process to clean damaged organelles and misfolded proteins. We have shown that
carboxyl-terminal modulator protein (CTMP) is increased in the brain with aging in rats. Our
ongoing study supported by the parent grant has shown that CTMP increase contributes to the
decreased autophagy in the brain of rats. Our preliminary data showed that there was an
increase in CTMP mRNA levels in the brain of old people. It is possible that our findings in rats
may be applicable in humans. Since decreased autophagy may contribute to cell senescence,
CTMP may regulate cell senescence. However, the role of CTMP in cell senescence is not
known in rodents and humans. Thus, we hypothesize that CTMP reduces autophagy and
induces senescence in the human induced pluripotent stem cells (iPSC) with or without AD
pathology. We will test this hypothesize in this supplement request project. iPSC is used
because it is not possible to test our hypothesis in humans under in vivo conditions and
iPSC holds a great potential in cell therapy for various diseases. iPSC generated from
healthy individual or from a patient with an AD mutation will be infected with lentivirus to
overexpress CTMP or silence CTMP expression. These cells will be subject to the evaluation of
autophagy and cell senescence. These studies may identify a molecular target for improving
the health of iPSC and advance our knowledge on the molecular process of cell
senescence in the presence or absence of AD pathology, an aging-dependent
neuropathology.

Public health relevance
Aging is the most significant risk factor for Alzheimer’s disease (AD), a dreadful disease in humans. We will determine the role of a protein in regulating a process called autophagy that is important to maintain cell health, in human cell health and aging. The findings from this project may ultimately help improve the health of humans.